Vermont Center for Cardiovascular and Brain Health

Project Summary:
Cerebral blood flow is precisely controlled to satisfy neuronal metabolic demands. Active neurons signal to the
vasculature via multiple neurovascular coupling mechanisms to increase regional blood flow in a phenomenon
known as functional hyperemia. The hyperemic response increases the frictional forces imposed by blood flow
onto endothelial cells of arterioles and capillaries. We have recently demonstrated that the Piezo1 channel is a
crucial mechanosensor in brain capillary endothelial cells, and that it mediates Ca2+ signals in response to
mechanical stimuli. Previous research has focused on mechanisms engaged downstream of endothelial Piezo1
activation, but how endothelial cell plasma membrane fluidity controls its activity remains unknown. In response
to the NIH Notice of Special Interest (NOT-GM-23-034) “Availability of Administrative Supplements to IDeA
Awards to Fund Team Science Development Projects,” we provide compelling preliminary evidence that lipid
domains enriched in cholesterol and phosphoinositides exist in central nervous system capillary networks.
Further, we propose and provide preliminary results that lipids affect Piezo1 activity. The parent award,
supported by NIGMS (P20GM135007), provides a platform to build sustainable research programs built on the
exceptional potential of early career faculty to study the vital health problems facing society: cardiovascular
disease, stroke and cognitive impairment. This Team Science proposal aims to lay the foundation and framework
for Drs. Harraz (current Project Director, P20GM135007) and Gonzales (former Project Director, P20GM130459)
to build upon their past productive collaborations and bring their expertise and techniques to synergistic work on
impactful biological questions. Herein, we hypothesize that the lipids cholesterol and phosphatidylinositol-4,5-
bisphosphate (PIP2) form domains in capillary networks, which determine capillary endothelial membrane fluidity
and Piezo1 activity. To test this hypothesis, the proposed Team Science project will use diverse, state-of-the-art
approaches, including patch-clamp electrophysiological techniques and engineered mouse models (Harraz Lab)
along with high-resolution vascular imaging (Gonzales Lab) to characterize the impact of membrane lipids on
endothelial Piezo1 activity. Completion of this project will foster collaboration between the two independent
research teams and will support the concept that Piezo1 activity is dictated by lipid microenvironment. These
studies will further establish a solid foundation that will lead to future independent funding (NIH R01 application),
which will further our careers as independent scientists.

Public health relevance
Narrative: Brain blood flow is essential for brain health. We discovered that blood flow dynamics are sensed by force sensors such as Piezo1, but it is unknown whether these sensors are affected by their lipid surroundings. In this Team Science Project, we will use advanced imaging and electrophysiological techniques to study the new idea that lipid domains are formed in the central nervous system vasculature, and that these domains control Piezo1 activity and therefore blood flow control.